Small LIVER Cancer: Development of a Multi-Level Intervention to Improve Access to CURE (LIVER:CURE)

Project Summary:
The long-term objective of this K08 application is to develop Dr. Resmi Charalel's capacity to discover practical
solutions to achieve equitable outcomes for small hepatocellular carcinoma (HCC) patients, a cancer
population where there is currently a large gap in care delivery from diagnosis to treatment. During the K08
award period, the proposed training activities will support Dr. Charalel in four educational and training
objectives that will allow Dr. Charalel to develop into an independent investigator who is able to implement
barriers and facilitators analyses, as well as stakeholder-engaged intervention development for timely small
HCC treatment and ultimately, increase appropriate treatment utilization for small HCCs. First, Dr. Charalel will
develop knowledge in qualitative research methods in order to investigate the barriers and facilitators to
treatment for small HCCs using reliable and reproducible methods. Second, she will develop expertise in
health equity research to better understand how to reduce inequities in the care delivery pathway and deliver
culturally sensitive healthcare. Third, Dr. Charalel will develop expertise in implementation science by
completing a rigorous certificate in Implementation Science including training in advanced trial methods
important to test the efficacy of interventions as an independent investigator. Finally, Dr. Charalel will pursue
professional development opportunities, specifically geared towards grant writing and collaboration. The three
research aims of this project proceed as follows: Aim 1 will identify barriers and facilitators of treatment for
small HCCs (less than 5 cm) using qualitative research methods. Specifically, Dr. Charalel will use focus
groups of patients who did not receive timely treatment (within 3 months) and semi-structured interviews with
providers and staff to develop a comprehensive understanding of the modifiable factors that contribute to
treatment utilization. Aim 2 will focus on iterative development of a multilevel intervention to facilitate timely
care to small HCC treatment in conjunction with a stakeholder advisory board. The multi-level intervention will
address patient-level, provider/staff-level and system-level factors that contribute to inequities and
inefficiencies in care delivery. Aim 3 will consist of a single arm, pilot feasibility and acceptability test of our
multi-level intervention in two hospitals including a tertiary care center and a community hospital to ensure
broad reproducibility. We will also obtain preliminary effectiveness data by comparing treatment rates and time
to treatment between our interventional cohort and historical controls. Together, the proposed research will
provide foundational work needed to conduct a randomized controlled trial testing the novel, multi-level
intervention developed in this proposal to assess its efficacy in providing timely treatment to curable, small
HCC patients and expanding cancer care delivery to this undertreated population. Thus, the outlined study
aims are aligned with the NCI's cancer moonshot goal to improve access to current and new standards of HCC
cancer care and thus reduce disparities in cancer care delivery.

Public health relevance
Project Narrative: Hepatocellular carcinoma (HCC) is one of the deadliest cancers worldwide; but when detected early, it is readily curable. Unfortunately, despite diagnosis, many patients do not receive the recommended curative treatment and some do not receive treatment at all. Our study will examine barriers and facilitators to treatment and develop a novel, multi-level intervention to improve access to timely small HCC treatment in order to reduce inequities in HCC care delivery.